Phase I Clinical Trial Unit for Therapeutics Against Infectious Diseases

The Phase I Clinical Trial Units provide a vehicle for the investigation of new therapeutic agents for the treatment of infectious disease.